Trabecular Meshwork Cytoskeletal Signaling-Regulation of Aqueous Humor Outflow

PROJECT SUMMARY
Dysregulated homeostatic mechanisms that lead to an increased resistance to aqueous humor (AH) outflow
through the trabecular pathway constitute the main cause for ocular hypertension (OHT), a key risk factor for
an irreversible blinding disease, glaucoma. The extracellular matrix (ECM) is well-recognized to play a crucial
role in modulation of AH outflow and intraocular pressure (IOP) via regulating the contractile, adhesive,
fibrogenic and permeability characteristics of the trabecular outflow pathway cells. There still exists a
fundamental gap in our understanding however, of how post-translational modifications of ECM proteins and
ECM degrading enzymes might influence trabecular meshwork (TM) cell behavior, AH outflow and IOP. The
broad objective of this proposal is to examine protein phosphorylation of ECM components and matrix
metalloproteinases (MMPs), and determine how this modification modulates AH outflow and IOP, with the goal
of uncovering novel insights into OHT etiology and developing efficacious strategies for glaucoma treatment.
The scientific premise is that protein tyrosine kinases and phosphatases in the AH secreted by TM and other
cell types play a vital role in homeostasis of AH outflow and IOP by modifying protein tyr-phosphorylation
status of ECM and MMPs that in turn influences TM cell contractile, adhesive, fibrogenic and barrier activities.
We hypothesize that deregulation of tyr-phosphorylation of ECM proteins and MMPs resulting from alterations
in the levels of secretory tyrosine kinases and phosphatases may be a key etiological contribution to impaired
AH outflow and elevated IOP in glaucoma. In support of this novel and paradigm shifting hypothesis, our recent
studies detected vertebrate lonesome kinase (VLK) and phosphatase and tensin homolog (PTEN) proteins in
human AH samples, and demonstrated that HTM cells secrete both enzymes. Significantly, VLK was shown to
regulate ECM tyr-phosphorylation, and contractile and adhesive activities of TM cells, and induced by TGF-β2
and dexamethasone in human TM cells, both of which are known to induce OHT.
Based on these promising and novel preliminary results, we have outlined three specific aims in this competing
proposal, focused on mechanistic investigations into the role(s) of VLK in: 1) regulation of intracellular signaling
pathways controlling TM cell contractile, cell-ECM & cell-cell adhesive, fibrogenic and permeability
characteristics, 2) Tyr-phosphorylation of TM cell ECM and MMPs, ECM organization and TM cell stiffness,
and 3) AH outflow and IOP, using human TM cells, human donor eyes and rats. These studies will utilize gene
targeting, proteomics, biophysical, histological and physiological approaches, and include an assessment of
changes in levels of VLK and PTEN in AH samples from glaucoma versus non-glaucoma (cataract) patients.
Completion of the novel studies proposed in this application is expected to uncover new understanding on the
role of tyr-phosphorylation of ECM proteins and MMPs in AH outflow and OHT etiology via altered outside-in
signaling, and to identify new and efficacious treatment strategies for lowering IOP in glaucoma patients.

Public health relevance
PROJECT NARRATIVE Glaucoma, a leading cause of irreversible blindness is commonly associated with elevated intraocular pressure (IOP). Lowering of elevated IOP has been proven to restore vision and is a mainstay of treatment for glaucoma patients. The broad objective of this competing proposal is to gain novel molecular insights into the etiology of ocular hypertension and identify strategies for development of efficacious ocular hypotensive agents. Studies to pursue this objective will determine, for the first time, the role of aqueous humor (AH) and trabecular meshwork cell secretory protein tyrosine kinases and phosphatases in regulating phosphorylation status of extracellular matrix and matrix metalloproteinases, and in modulation of AH outflow and IOP in both normal and glaucomatous eyes.